PROTECTIVE EFFECTS OF GARLIC DERIVATIVES IN LUNG

Garlic constituents including diallyl sulfone (DAS02) have been identified as potential protective agents, but the basis for the effects ar poorly understood, especially in the lung, a tissue that is susceptible to chemically-induced toxicities and carinogenesis. The long-term objectives of this application are to (1) to determine the potential inhibitory effects of garlic constituents on pulmonary toxicity and carcinogenicity, and 92) to identify the mechanisms by which garlic constituents protect from these adverse effects. The proposed studies will use an in vivo murine model of lung tumorigenesis induced by the carbamate compounds, ethyl carbamate (EC) and vinyl carbamate (VC). In vitro studies will use microsomal preparations from the lungs of mice and humans. The specific aims are as follows: 1) Investigate the potential inhibitory effects of DA802 on metabolism of EC and VC by cytochrome P450 CYP2EI. Lung microsomal incubation will be performed with EC or VC to determine the extent to which DAS02 inhibits carbamate metabolism. 2) Investigate the inhibitory effects of DAS02 on the formation of VC expoxide (VC0), the metabolite formed from EC and VC. The VC0 will be captured with glutathione (GSH) as the VC0-GSH conjugate in microsomal incubations. Incubation will also be performed with DAS02 or microsomes prepared from mice treated with garlic homogenates to determine the extent to which garlic constituents exert inhibitory effects. 3) Investigate the potential sex- related difference in formation of the VC0-GSH conjugate. Incubations will be performed with microsomes from male and female mice and humans. 4) Investigate the potential of DAS02 to inhibit the formation of carbamate-induced DNA adducts. 32_-postlabeling analyses will be used to identify the DNA adducts formed from exposure to EC or VC, and the extent to which DAS02 inhibits their formation. 5) Determine potential inhibition of lung tumors formed from the carbamates by garlic constituents. Mice will be treated with DAS02 or garlic homogenates before treatment with EC or VC, and the incidence and number of lung tumors generated determined.